Project 3: Control of cardiac transcription by MEF2 and myocardin

PROJECT SUMMARY/ABSTRACT
PROJECT 3
Cardiovascular disease, including heart failure, is the most common cause of mortality in adults, and
congenital heart defects are the most common form of birth defects in the US. An important concept that has
emerged in recent years is that disruptions of cardiac transcription factor networks play important roles in
congenital heart defects and in heart failure in adults. MEF2C is one of the core cardiac transcription factors
and is required for cardiac development and for postnatal cardiac gene expression and homeostasis. MEF2C
functions as signal responsive transcription factor that interacts with numerous co-regulator proteins to control
gene expression, yet much remains to be determined about how MEF2C functions in the heart. The most
potent transcriptional coactivator for MEF2C described to date is myocardin. MEF2C specifically interacts with
a long isoform of myocardin (myocardin-935) to synergistically activate cardiac transcription. Preliminary
studies identified a novel bridging mechanism whereby two myocardin-935 molecules interact with MEF2C and
with each other via a leucine zipper (LZ) dimerization motif to cooperatively activate paired MEF2 sites,
supporting a central role for myocardin dimerization for activation of MEF2-dependent cardiac genes.
Furthermore, in silico analyses of cardiac enhancers suggests that paired MEF2 sites are prevalent and occur
more frequently than predicted by chance specifically in cardiac enhancers. However, whether these
enhancers are bona fide targets of the MEF2C-myocardin complex and how myocardin dimerization influences
activity of these enhancers and gene expression in vivo remains to be determined. Additional, unpublished
preliminary studies have identified a family with congenital heart defects likely caused by an in-frame
microdeletion that results in loss of the myocardin LZ dimerization motif. Similarly, unpublished work shows
that mice with an analogous deletion the leucine zipper domain of myocardin die with congenital heart defects.
This project will test the hypothesis that the MEF2C-myocardin complex recruits a larger transcriptional
coregulatory complex, which is influenced by upstream signaling and myocardin dimerization to regulate
cardiac gene expression. To test this overall hypothesis, this project will define the interaction partners of
MEF2C and myocardin in the embryonic and adult heart and will identify the phosphorylation sites and other
modifications on MEF2C and myocardin. This will provide critical insight into the post-translational regulation
of these key cardiac transcription factors. This project will also utilize RNA-seq, ChIP-seq, and other genome-
wide approaches from embryos and endogenous tissues to identify transcriptional targets of the MEF2C-
myocardin complex and will determine how myocardin dimerization influences the complex and downstream
gene expression. Finally, this project will determine the requirement for myocardin dimerization for heart
development in vivo by examining the lethal heart development phenotype in myocardin leucine zipper mutant
mice and will identify gene expression changes associated with loss of myocardin dimerization.